Fourier transform infrared biodosimetry on skin

PROJECT SUMMARY
We aim to develop a non-invasive, painless biodosimeter for use during triage after a radiological
emergency. Our preliminary data showed that Fourier transform infrared attenuated total reflection (FTIR-ATR)
imaging coupled to statistical machine learning models is capable of distinguishing irradiated from control mice
at doses as low as 0.1 Gy for as long as 90 days after radiation exposure. To further develop this signature, and
to determine the ability to discriminate between radiation doses, we will first increase our power of detection by
expanding our studies to human skin explants. Statistical machine learning models will be used to develop an
FTIR-based signature that can distinguish irradiated from unirradiated animals and accurately determine
radiation dose and time since exposure for triage. We will then use ambient infrared laser ablation mass
spectrometry to identify the biomolecules that underly the radiation-specific response signature in the skin and
address confounders. This novel, non-invasive procedure will lay the groundwork for future applications of
deployable imaging devices for biodosimetry at population scales – a valuable tool for radiobiology,
epidemiology, and monitoring. Further, because only hundreds of samples were required to learn highly
discriminative signatures in our pilot study, this study will contribute to developing human-relevant diagnostic
capabilities.

Public health relevance
PROJECT NARRATIVE In the event of a nuclear bioterrorist event or large-scale nuclear accident (e.g. the tsunami-damaged nuclear reactors in Japan), fast and reliable bioassays are needed to identify radiation-exposed individuals and assess an individual’s absorbed radiation dose. This is especially important during the first few days after exposure when dose information would identify those victims who could benefit the most by medical intervention. This project aims to develop a non-invasive, painless biodosimeter on skin for use during triage after a radiological emergency.